Influences of Early and Later Life Events on Cognition and All-Cause Dementia in China

Project Summary
Rising life expectancy is contributing to rapid increases in the size of the older population and is
expected to lead to a sharp rise in Alzheimer’s disease and Alzheimer’s disease related
dementias from about 47 million people worldwide today, to potentially more than 140 million in
2050. However, recent population studies have found that the incidence of Alzheimer’s disease
and Alzheimer’s disease related dementias is lower than that indicated by previous projections
in some countries, but greater in others. Lifestyle factors as well as environmental factors
might reduce or increase an individual’s risk of developing dementia. We propose to advance
our understanding of protective and risk factors for late-life cognitive decline and Alzheimer’s
disease and Alzheimer’s disease-related dementias (hereafter referred to as dementia) in China.
We propose a novel life-course model of risk factors, building on the recently proposed model by
the Lancet commission, which links dementia risk to early and mid-life factors, within the
context of historical, institutional, and physical environments, including obesity, diabetes
hearing loss, visual impairment, smoking, drinking, depression, physical inactivity, social
isolation, and socioeconomic status.
Specifically, this project aims to further study early and mid-life personal, family, community,
and external factors that may contribute to late-life cognition and dementia risk using new,
retrospective life-history interview data in China.

Public health relevance
Project Narra+ve Alzheimer’s disease (AD) is a large and growing problem aﬀec9ng socie9es in both high- and low-income countries. Alzheimer’s disease and other forms of demen9a are debilita9ng to the pa9ents aﬀected but can also have a devasta9ng eﬀect on their families and friends.